Aptamers as Novel Inhibitors of the Neurotoxin Beta-methylamino-L-alanine (BMAA)

PROJECT SUMMARY
Exposure to specific environmental factors are believed to play a role in the development of many neural
pathologies. Early studies linked chronic exposure to the Cyanobacteria biotoxin Beta methylamino-L-alanine
(BMAA) ingestion of contaminated plant and animal tissue with the development of Amyotrophic Lateral
Sclerosis/Parkinsonism-Dementia Complex (ALS/PDC) within certain Indigenous populations of Guam and
Japan. More recent studies in primate models and cell culture have further supported the association of BMAA
with ALS/PDC. Taken together, the stage is set to explore in greater detail the relationship between BMAA and
ALS/PDC at the cellular/molecular level. In this study, we propose to elucidate the mechanisms of BMAA-
induced toxicity in cell culture through the use of cell functional assays, signaling pathway analysis, and global
expression analysis in human cell lines. We further propose to develop and test the inhibitory potential of novel
aptamers on BMAA’s activity in these cell lines. This study will provide mechanistic information regarding
BMAA’s functions at the cellular level and provide data evaluating aptamers as a possible novel therapeutic for
ALS/PDC. Future long-range experiments building on our generated data would investigate the mechanism
and physiological effects of BMAA on specific identified signaling pathways and evaluate the use of aptamer-
based therapeutics in animal models.

Public health relevance
PROJECT NARRATIVE The role of the biotoxin BMAA in promoting human disease will be investigated by establishing its functional effects in several human cell lines using a combination of gene expression and functional assays. Novel aptamers targeting BMAA will be generated and tested in cell culture models for their potential in inhibiting BMAA functions.